Quantification of Iron Oxide Nanoparticles in Cryopreserved Kidneys with Longitudinally Detected Electron Paramagnetic Resonance

Abstract
Unfortunately, ~20% of kidneys donated for transplant are discarded due to short storage viability (~24-36 h).
Cryopreservation decreases storage temperatures below -140oC, enabling storage of kidneys for months to
years. To re-warm cryopreserved kidneys without ice formation and cracking, fast and even warming is needed.
For this, iron oxide nanoparticles (IONPs) can be perfused into them prior to cooling, then radiofrequency waves
can be applied to rapidly rotate their magnetic moments, causing local heating around IONPs and kidney re-
warming. Despite initial success of this method in rat kidneys, the complex behavior of IONPs (uneven particle
distribution, aggregation, etc.) limits reproducibility and is a major bottleneck in its translation to human organs.
Currently there is no low-cost method to nondestructively track IONPs in organs across concentrations of interest.
Thus, there is a need for precise monitoring of IONP concentrations (1) after perfusion, to ensure even IONP
distribution and therefore even kidney heating and viability, and (2) prior to transplant, to prevent potential IONP-
related iron toxicity post-transplant. To address this, our lab has developed a low-cost, longitudinally detected
electron paramagnetic resonance (LOD-EPR) system that can directly detect electrons in IONPs. LOD-EPR is
sensitive to IONP concentration in solution and in IONP-loaded kidney biopsies with improved accuracy in tissue
compared to nuclear magnetic resonance (NMR) based on data under review. This project aims to develop
LOD-EPR into an IONP quantification and imaging system for cryopreserved rat kidneys and compare
its accuracy to similar techniques such as magnetic particle imaging, and micro-CT. Aim 1 will improve
the sensitivity of LOD-EPR through hardware changes on receive and transmit and increase the bore size to fit
whole rat kidneys. Aim 2 will develop the LOD-EPR system into an imaging system primarily by implementing
permanent magnet-based linear gradients. Its IONP quantification accuracy and imaging resolution will be
compared to magnetic particle imaging and micro-CT in IONP-perfused whole rat kidneys. By enabling IONP
monitoring during the cryopreservation process, IONP synthesis, kidney perfusion, and radiofrequency heating
parameters can be fully optimized for increased kidney viability during re-warming. This will ultimately expedite
development of kidney cryopreservation to increase transplant availability.

Public health relevance
Project Narrative The proposed research is aimed at engineering a novel longitudinally-detected electron paramagnetic resonance system for inexpensively and noninvasively quantifying iron oxide nanoparticles in tissues. This system will be used to determine concentrations of nanoparticles in rat kidneys that have been cryopreserved for transplantation. The measurements from this system will be used to address bottlenecks in kidney cryopreservation research, thus increasing the number and quality of kidneys available for transplant.